Enrichment Program

PROJECT SUMMARY (ENRICHMENT PROGRAM)
The goal of the CMSDLD Enrichment Program is to provide unique programming to advance the scientific
education and professional development of digestive and liver disease researchers at all levels, ranging from
undergraduate students to senior professors.
The Enrichment series has been rebuilt over the last two years, with new programs to better target the needs of
the restructured Research Base and Theme Areas as well as to provide expanded career development offerings
for junior researchers. Enrichment activities fall into three categories: 1) scientific programming for the CMSDLD
community as a whole, including a Research Seminar series, regular trainee research update sessions, an
Advances in Technology Series, and an Annual Symposium, highlighting the latest scientific and technical
advances; 2) mentoring and professional development programs, including Grant Writing and Lab Management
Seminar series, regular Mini-Poster Sessions, extensive oral presentation opportunities, and a junior faculty
exchange program; and 3) support for training programs for undergraduates, medical students, graduate
students, and postdoctoral fellows.
Additional goals of the enrichment program are to enhance cohesion in the Center in the setting of changes to
the Research Base, the reorganization of Center themes, and the addition of a new core; and to foster diversity,
equity, and inclusion through both the scientific and professional development programming.
Collectively, these activities will increase the pool of well-trained digestive and liver disease researchers, bolster
the trajectory of scientists interested in digestive and liver disease research, generate scientific excitement, and
provide state-of-the-art technical education to Center participants at all career stages.